Defining the metabolic-epigenetic regulation of neuronal chromatin by alcohol

Abstract
Alcohol use disorder (AUD) represents a significant public health issue with substantial psychological and
economic impacts on individuals, families, and communities. A critical gap persists in understanding the
molecular underpinnings of alcohol addiction, particularly in the context of increasing youth binge drinking.
Current treatments are limited, highlighting the need for research into the molecular mechanisms of AUD,
including the role of epigenetic modifications following chronic alcohol exposure, such as those mediated by
acetate via ACSS2 (Mews et al., 2019). This study focuses on the transport pathways of alcohol-derived
acetate into the brain, investigating the role of monocarboxylate transporters (MCTs). The differential
expression of MCT isoforms between neurons and astrocytes also suggests a complex, cell-type-specific role
in AUD, warranting further investigation. This supplementary grant proposal aims to elucidate the role of MCT4
in facilitating the entry of alcohol-derived acetate into the brain, thus contributing to alcohol-induced epigenetic
changes. This research is designed to build upon the foundational discoveries of Mews et al., exploring the
regulation of brain histone acetylation by acetate derived from alcohol metabolism in the liver and its transport
into hippocampal neurons and astrocytes. By exploring alcohol-derived acetate and its transport into neurons,
this research will operate within the scope of the parent grant and complement its objectives while exploring
distinct experimental aims. Additionally, this project will serve as a critical component of Naomi Kassahun’s
training in molecular techniques and independent research towards a F31 grant application, integrating with
her doctoral research objectives and enhancing her development as a future leader in addiction research. This
alignment ensures a comprehensive approach to both advancing AUD research and fostering significant
scientific development.

Public health relevance
Alcohol Use Disorder (AUD) presents significant psychological and economic burdens, underscoring the need for a deeper understanding of its molecular underpinnings, especially the role of epigenetic modifications induced by alcohol-derived acetate. This supplementary grant proposal focuses on examining the transport mechanisms of alcohol-derived acetate into the brain, particularly through the monocarboxylate transporter MCT4, and its impact on histone acetylation in neurons and astrocytes. By advancing our knowledge of acetate transport and its epigenetic effects, this project will not only fill critical gaps in AUD research but also significantly enhance Naomi Kassahun’s training in molecular techniques and her development as a leader in the alcohol research field.